State economic support policies on the prevention of child abuse and neglect during and post the COVID-19 pandemic: Bridging evidence with policy implementation

PROJECT SUMMARY/ABSTRACT
Child abuse and neglect (CAN) is a pressing and costly public health issue with negative lifelong
consequences. Children living in economically disadvantaged families and communities are at high risk for
experiencing CAN or receiving CAN reports. Though not all types of CAN are preventable, theories and
empirical studies suggest policies strengthening economic security may be potentially effective strategies
to prevent a significant portion of CAN by improving caregiving capacity and parental well-being. The
COVID-19 pandemic (hereafter, COVID) has exacerbated economic hardship and parental stress, creating
additional risks related to CAN. To address material hardship and health inequity, states with differing
contexts developed or expanded innovative economic support policies, with various approaches in timing,
policy selection, and implementation. Understanding how COVID-related policy changes impacted CAN is
essential to inform the design of CAN prevention strategies in the COVID-recovery era and plan for future
disasters. Further, central to recovery from COVID (and other similar disasters) is the mobilization of
community resources and collective actions by community members. Although the goal of macro-level
policy evaluation is to improve community-based CAN prevention practices, little effort has been made to
engage local communities in the identification and implementation of community-based policies.
Leveraging a natural experimental design with nationwide data, along with a community-based
participatory design, this study will 1) examine how changes in state-based economic support policies
during and post COVID, individually and in synergy with each other, impact CAN report and related family
stressors; 2) investigate how states' policy effects vary by county poverty rate, racial/ethnic composition,
and rural/urban status; 3) engage families and service providers in how policies are implemented at the
local level with the aim to identify effective CAN prevention strategies in local community settings.
To accomplish the proposed project goals, the PI will receive mentorship from a group of interdisciplinary
experts, including Drs. Melissa Jonson-Reid, Derek Brown, and Patricia Kohl, take full advantage of the
extensive resources at the NIH-funded Center for Innovation in Child Maltreatment Policy, Research and
Training (P50HD096719), and extend existing partnerships with community stakeholders in Missouri. The
PI will receive training in 1) performing policy evaluations with rigorous causal inference methodologies; 2)
managing and analyzing large-scale ecological data; 3) conducting community-based participatory
research; 4) developing NIH grants and disseminating research evidence for CAN prevention. This K01
award will enable the PI to conduct independent, community-engaged, and policy-relevant research
informing states' selection and implementation of policies to prevent CAN.

Public health relevance
PROJECT NARRATIVE Child abuse and neglect (CAN) is a pressing and costly public health issue, and economic support policies may be effective strategies towards reducing CAN by strengthening families' economic well-being and reducing related stress. This proposed project will rigorously examine the impact of state-based economic support policies during and post COVID in preventing CAN, and engage families and service providers in how policies are implemented at the local level to identify effective CAN prevention strategies in community settings. Findings will inform states' selection and implementation of policies to prevent CAN and prepare the PI to engage in independent, community-based, and policy-relevant research.